Training Program

PROJECT SUMMARY: Training Program
Despite the urgent need to address maternal mortality, severe morbidity, and disparities, previous efforts have
failed to improve maternal health outcomes. Notably, most research efforts to reduce maternal mortality and
severe maternal morbidity have focused on clinical care and have not addressed the role of the maternal
health workforce in the community. To effectively reduce maternal health inequities and improve outcomes,
more research focused on structural and social determinants maternal health is needed, especially research
conducted in underserved areas by researchers from those communities. To this end, our proposed
Mississippi Delta Research Center of Excellence for Maternal Health will include a training program for
early-stage investigators focused on addressing the interpersonal and structural factors that affect maternal
health outcomes in at-risk communities. In meeting the challenges posed by the social determinants of health,
there is increasing recognition of the importance of research conducted with people and in places with the
greatest vulnerability. This includes valuing the potential of scientists working in historically under-resourced
institutions and with underserved communities, such as researchers at institutions located in limited-resource
regions of the Southern United States and at Historically Black Colleges and Universities (HBCUs) across the
rural–urban continuum. Our proposed training program will focus on early-stage investigators at two
Mississippi HBCUs, Jackson State University and Alcorn State University, and will leverage existing resources
in maternal health training within these universities, at the Southern Rural Development Center based at
Mississippi State University, and at Harvard University. Our collaborative approach will capitalize on the
expertise of our program leads and community partners in maternal health systems and the strong existing
relationships among the various participating institutions. The overarching goal of our research training
program is to foster culturally responsive research that addresses maternal health disparities. We will achieve
this goal through (1) increasing the number of postdoctoral trainees, junior faculty, and other early-stage
investigators engaging in research related to biological, behavioral, environmental, sociocultural, and/or
structural factors that affect pregnancy-related and pregnancy-associated morbidity and mortality and severe
maternal morbidity in the Mississippi Delta; (2) providing applied research experiences to predoctoral fellows
as the next generation of maternal health research professionals; and (3) providing outreach opportunities to
reach a broader audience. Our extensive research training program will support the goals of the center’s
research projects, address the interpersonal and structural factors that affect maternal health outcomes, and
prepare the next generation of clinical researchers focused on maternal health outcomes and equity.
1

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal aims to establish the Jackson State University (JSU) - Mississippi Delta Research Center of Excellence for Maternal Health to address preventable maternal mortality, decrease severe maternal morbidity, and promote maternal health equity in partnership with the Mississippi Delta community. This research center will conduct two multi-layered research projects utilizing community health partners, inclusive of an extensive research training program for early-stage investigators, to address the interpersonal and structural factors that affect maternal outcomes. By establishing an equal partnership with the community in all parts of the process, we envision that this research center will overcome structural and interpersonal barriers to high-quality, culturally competent postpartum maternal care and ultimately improve maternal morbidity and mortality for women residing in the Mississippi Delta.